Reposition and Optimization of Deferiprone for Breast Cancer Therapy

Project Summary/Abstract: In 2020 there will be ~ 276,480 estimated new cases of invasive breast cancer
(BCa) among women in the US, causing an estimated ~ 42,170 deaths. Two common mechanisms for the
sustenance of BCa are epigenetic dysfunction and the malfunction of endocrine proteins such as estrogen
receptor (ER). The specific focus of the studies proposed in this application is to repurpose deferiprone (Def),
an FDA-approved iron chelator, as a template for the discovery of novel histone lysine demethylase (KDM)
inhibitors optimized for BCa therapy. Most compounds that have been or are being developed clinically exhibit
greater efficacy for a subtype of BCa. In this regard, therapeutic interventions that capitalize on ER signaling
malfunctions, a driver of more than 70% of BCas, have enjoyed measured success in BCa therapy and/or chemo-
prevention. However, despite initial benefits, most patients eventually relapse due to acquired resistance to these
drugs. Additionally, there are no targeted treatment options for triple-negative breast cancer (TNBC), a BCa
subtype lacking ER, Human Epidermal Growth Factor receptor 2 (HER2), and Progesterone Receptor (PR) and
which accounts for over 20% of BCa incidence. Therefore, there is an unmet medical need for increasingly
selective and potent drugs to treat early and resistant stages of all BCa subtypes.
BCa viability, regardless of ER expression status, depends on an extensive network of epigenetic
modifiers - histone mark writers, readers and erasers. Bioinformatic and functional analysis have identified
specific subfamilies of the amino oxidase and Jumonji family of histone lysine demethylases (KDMs), histone
methyltransferases (HMTs) and histone deacetylase (HDACs) as essential in supporting ERα signaling
activation. Among these epigenetic modifiers, KDM1, KDM3A, KDM5A, KDM5B and KDM6A are exquisitely
wired into ERα signaling and are collectively vital for BCa cell viability. Moreover, studies have implicated KDMs
such as KDM6A in other ER-independent epigenetic reprograming which sustains TNBC as well. Unlike ERα
signaling, pharmacological inhibition of KDMs has not been clinically validated. Although inhibition of KDM3A,
KDM5A, KDM5B and KDM6A caused BCa cells growth arrest in vitro and in vivo, there are however precedents
for compensation among KDM paralogs in tumor models generated by selective deletion of a paralog member.
This study hypothesizes that collective inhibition of KDM paralogs implicated in BCa etiology will blunt the
possibility of compensation among KDM paralogs that could occur from paralog selective inhibition, resulting in
novel selective and potent drugs to treat BCa regardless of the cell ER expression status. The proposed study
is designed to test this hypothesis. The specific aims are: 1) Develop Def-based KDM inhibitors with favorable
toxicological and pharmacokinetic (PK) properties. 2) Characterize the correlation between intracellular on-target
effects (pharmacodynamics) and whole cell antiproliferative activity. 3) Investigate the in vivo efficacy of lead
compounds in five BCa murine models.

Public health relevance
Project Narrative/Relevance: Breast cancer (BCa) ranks second only to lung cancer as the leading cause of US cancer deaths in women. This application describes a preclinical study aimed at repurposing deferiprone (Def), an FDA-approved drug, as a template for the discovery of novel histone lysine demethylase (KDM) inhibitors optimized for BCa therapy.